Elucidating the Mechanisms of Translational Approaches to Enhance Recovery of Aged Muscle

PROJECT SUMMARY/ABSTRACT
Muscle atrophy resulting from physical disuse (such as post-surgery, or with extended periods of physical
inactivity) increases fall risk and disability in older adults. With a growing aging population, the dysfunctions
related to physical disuse will be widespread contributing to large-scale decreases in healthspan, and increases
in morbidities and hospitalizations as skeletal muscle health is important for whole body glucose regulation,
postural stability/balance, and strength to perform activities of daily living (independence). Unfortunately, physical
rehabilitation alone does not always adequately restore muscle size and function in older populations. The use
of mechanistic-based, translational therapeutics may provide a much-needed solution to improve muscle
recovery in older adults following disuse, however, well designed, translational pre-clinical trials testing
therapeutic agents are required. Here, in the F99 phase, I propose a rigorous pre-clinical trial utilizing a metformin
and leucine combination treatment (MET+LEU) to promote muscle recovery from disuse in aged mice. My
current progress supports that MET+LEU promotes recovery from disuse in aged mice as evidenced by
increased strength, satellite cells and reduced muscle fibrosis. Through in vitro and in vivo methods, we aim to
test the mechanism of MET+LEU action. The goal of this work is to identify if MET+LEU treatment confers
positive benefits in a skeletal muscle cell autonomous fashion, and if the effects of MET+LEU are regulated
through the SIRT1-AMPKα-PGC-1α signaling axis, implicated to be targeted by MET+LEU. During the K00
phase, I will work under an expert in muscle aging specifically in extracellular matrix remodeling and fibroblast-
satellite cell crosstalk, to further elucidate the effects of MET+LEU and other translational therapeutics on muscle
health. In doing so, we will become closer to providing a solution to promote muscle recovery following disuse
by furthering our knowledge on how MET+LEU and other translationally relevant therapies influence muscle
dysfunction with disuse and aging. Through these two critical phases and the mentoring across two exceptional
academic institutions, I will fill current gaps in my skillset using skeletal muscle cell genetic manipulation, genetic
mouse models, guidance in utilizing potential translatable pharmaceuticals in pre-clinical research, exposure to
related clinical trials, and new knowledge and techniques to investigate cell-to-cell crosstalk in aging muscle. I
will additionally gain grant writing and outreach skills to promote diversity in health-related biomedical research.
These skills gained will enhance my long-term career goal to become a tenured professor running an
independent, NIH-funding laboratory focused on novel, translatable therapeutics to promote muscle
health in aging.

Public health relevance
PROJECT NARRATIVE Impaired recovery from skeletal muscle disuse in aging results in heightened risk of disability and falls contributing to decreased healthspan. During the F99/K00 phases, I will study the mechanisms of novel therapeutic compounds and cellular interactions to promote muscle recovery in aged mice. This proposal will be guided by a panel of muscle aging experts and training experiences across various disciplines and institutions to promote my training in muscle aging research.